CEREBROSPINAL FLUID CHEMISTRY IN AGING AND DEMENTIA

Cerebrospinal fluid concentrations of homovanillic acid, 5-hydroxindoleacetic acid, norepinephrine and 3-methoxy 4-hydroxphenylethylene glycol did not differ significantly between patients with Alzheimer's disease and age matched controls, and were not correlated with age in healthy men. Spinal fluid concentrations of choline increased with age in healthy men, and were higher in young adults with Down syndrome than in age matched controls. CSF biopterin, a coenzyme for tyrosine and tryptophan hydroxylase, was lower in patients with Alzheimer's disease than in controls, and was correlated with concentrations of 5-hydroxy-indoleacetic acid and homovanillic acid. Corticotropin releasing factor, a neuropeptide, was significantly reduced in the cerebrospinal fluid of patients with Alzheimer's disease as compared to controls, as was peptidyl-alpha-amidation activity, suggesting a loss of neurons which produce amidated neuropeptides. Ratios of albumin and immunoglobulin between cerebrospinal fluid and plasma were normal in Alzheimer's patients, suggesting that the blood brain barrier is intact. Neuron-specific enolase, a glycolytic enzyme enolase, was significantly reduced in cerebrospinal fluid of patients with Alzheimer's disease.